Impact of cholesterol and its metabolites on breast cancer progression

PROJECT SUMMARY
Despite increased survivorship among patients, breast cancer remains the second leading cause of cancer-
related death in women. Associated mortality is most often due to metastatic disease. The magnitude of this
problem provides a strong impetus for studies that may lead to the development of new chemopreventative
strategies and/or lifestyle changes to prevent and treat cancer metastasis. In this regard, epidemiologic studies
have found that elevated circulating cholesterol is a risk factor for breast cancer metastasis. On the other hand,
patients taking inhibitors of HMG-CoA reductase (statins) demonstrate increased recurrence free survival. The
observation that the circulating concentrations of a primary metabolite of cholesterol, 27-hydroxycholesterol
(27HC), are correlated with those of cholesterol, together with the knowledge that this metabolite can serve as
a ligand for both the estrogen receptors (ERs) and liver X receptors (LXRs), suggests a potential mechanistic
link between hypercholesterolemia and breast cancer metastasis. Indeed, we have found that 27HC robustly
increases metastasis in several murine models of mammary cancer, while metastasis is reduced in mice lacking
the capacity to synthesize 27HC. Intriguingly, we have found that the pro-metastatic effects of 27HC are due to
its ability to impact the host immune system. Furthermore, extracellular vesicles released from immune cells
treated with 27HC possess pro-metastatic properties. However, the precise receptor-mediated mechanisms by
which 27HC influences immune cells or extracellular vesicle cargo remain unknown. We hypothesize that 27HC
alters the immune micro-environment via selective modulation of the ERs and LXRs culminating in the
increased cancer cell colonization of distal sites. We will systematically test this hypothesis by (1) identifying
the receptor-mediated mechanisms responsible for the actions of 27HC including the determination of selective
modulation of the ERs and LXRs by different oxysterols, (2) evaluating the mechanisms by which 27HC regulates
extracellular vesicle cargo and release, and (3) elucidating the mechanisms by which 27HC influences immune
cells to facilitate metastasis. A series of integrated experiments will determine both the cellular and biochemical
mechanisms behind the 27HC promotion of metastasis. This information will determine the best approaches for
targeting the ER and LXR axes within immune cells, important information given the recently initiated clinical
trials targeting these receptors. It is anticipated that this line of investigation will lead to the near-term
development of new strategies to treat and prevent metastatic breast cancer. This research is of significant
importance, given the high prevalence of hypercholesterolemia, stark differences in the effects of ligands for the
ERs and LXRs, and that the majority (>90%) of mortality associated with breast cancer is due to metastatic
disease.

Public health relevance
PROJECT NARRATIVE Elevated circulating cholesterol is a risk factor for the development of metastatic breast cancer, while cholesterol lowering medications are protective, strongly implicating the actions of cholesterol in this stage of disease. This represents a significant burden to public health since (a) breast cancer is the second leading cause of cancer related death amongst women, (b) associated mortality is most often due to metastasis, and (c) there is a high incidence of hypercholesterolemia in the American population. The research proposed herein investigates the cellular and biochemical mechanisms by which cholesterol metabolites mediate the metastatic effects of cholesterol and is expected to identify novel pathways and therapeutic strategies for the prevention and treatment of metastatic breast cancer.